Mild Cognitive Impairment: A Prospective Community Study

Mild Cognitive Impairment: A Prospective Community Study. Dementia is a
leading cause of disability and death in older adults. Its incidence increases exponentially with
age. Identifying independent risk factors and valid disease markers are critical steps towards
prevention, improved diagnosis, and treatment. To enhance clinical and public health care,
these factors must be identified in population settings. We seek to extend, for a further five
years, a 15-year prospective population-based study of mild cognitive impairment (MCI) and
dementia in a low SES-area of southwestern Pennsylvania. The original richly characterized
cohort is now aged 80+, and at maximum risk for dementia; we have replenished the cohort by
recruiting additional participants currently aged 65-74, for a total current sample ~1100.
Our objective remains to identify, at the population level, risk factors for clinically
relevant adverse cognitive outcomes of MCI, cognitive decline, and progression to dementia.
We propose a new set of specific aims investigating novel disease markers in relation to these
outcomes. Our new high performing mass-spectrometry-based plasma β amyloid (Aβ) assay
holds potential for affordable non-invasive screening for Alzheimer's disease. 7T MRI brain
scans will allow in-depth imaging of cerebrovascular integrity in a subgroup and help
understand the role of small vessel disease (SVD) in cognitive decline and dementia. Non-
invasive wrist actigraphy will measure sleep-wake rhythms which we will examine in relation to
the cognitive outcomes, Aβ and SVD. GWAS and transcriptomics will allow us to examine
genome-wide genetic and gene expression data. We will assess the relationships of these three
biomarkers (Aβ, SVD, sleep), along with genomics and gene expression, and their mutual
interactions, to the clinically relevant outcomes of cognitive decline and dementia.
New light shed on mechanisms underlying these disorders, using modeling techniques to
account for biases and generalize results from sub-samples back to the entire cohort, will lead to
new insights to help reduce the public health burden of dementia.

Public health relevance
Mild Cognitive Impairment: A Prospective Community Study. This study of dementia and cognitive decline is being conducted in a population-based cohort of older adults from a “Rust Belt” community of relatively low socio-economic status. The overall goal of the study is to identify factors which might increase risk of dementia and cognitive decline, so that steps can be taken to reduce these risks, thus reducing the risk of dementia and improving the health of older adults in the community.